The Mechanism of Hematological Abnormalities in Systemic Autoimmunity

ABSTRACT
Systemic autoimmune diseases such as systemic lupus erythematosus (SLE) are mediated by autoantibodies
against key tissue constituents, accompanied by the activation of innate immune system. In addition, systemic
autoimmunity is frequently associated with hematological complications such as lymphopenia, anemia and/or
thrombocytopenia, which can be debilitating and even life-threatening. These abnormalities are typically
considered as isolated symptoms caused by autoantibodies against the respective blood cell types, and are
treated by immunosuppressive therapies. On the other hand, it is possible that frequent hematopoietic
abnormalities in SLE may reflect a defect in the source of hematopoiesis, i.e. hematopoietic stem cells (HSC)
and/or progenitors. This model has important implications for the pathogenesis and treatment of SLE;
however, it remains to be supported by genetic and mechanistic evidence. Our preliminary studies suggest
that the bone marrow from mice with SLE-like disease showed impaired ability to reconstitute irradiated
recipients. Moreover, HSCs in moribund mice showed increased proliferation and upregulation of transcripts
associated with stem cell exhaustion. We therefore hypothesize that clinical SLE-like disease impairs the
activity of HSC, which may further exacerbate hematological abnormalities and inflammation. This hypothesis
will be tested using two Specific Aims. In Aim 1, we will characterize HSC impairment in a mouse model of
SLE-like disease, including its cell-extrinsic nature and relevance to endogenous hematopoiesis. In Aim 2,
we will characterize the epigenome of disease-affected HSC, as well as molecular pathways that cause HSC
impairment in this model. Collectively, these studies may support the paradigm of impaired HSC activity as a
source of hematopoietic abnormalities and "trained autoimmunity" in SLE. As such, they may pave the way
for future studies of stem/progenitor function in human SLE and of its potential therapeutic modulation.

Public health relevance
NARRATIVE Systemic autoimmune diseases such as systemic lupus erythematosus (SLE) are frequently associated with hematological complications such as lymphopenia, anemia and/or thrombocytopenia, which can be debilitating and even life-threatening. The proposed studies will dissect the mechanism of these abnormalities, paving the way for improved strategies for their treatment.